ADMINISTRATIVE CORE

The administrative core will be responsible for the overall administration and management of the Program Project. This core will be directed by Dr. Walter J. Koch, the Principal Investigator of the Program Project Grant. The Administrative Core Functions include: 1. Overall scientific coordination of the research objectives of the Program Project Grant. This includes plotting strategies for new ideas and research directions related to the central theme and potentially phasing out unproductive projects. This will be done in concert with input from both the Internal and External advisory committees. 2. Following and implementing all guidelines for Program Project Grants, including administering the budget in accordance with all NIH policies, recommendations of the NHLBI and the guidelines of Thomas Jefferson University. 3. Monitor all project and core budgets, including the preparation of annual budgets and budget planning for optimal efficiency. 4. Arrange, support and direct regular meetings of the Internal Advisory Committee and External Advisory Committee with the PPG investigators and core directors. 5. Allocate travel funds among the investigators of the PPG. The goal of the Program Project is to prioritize travel money to investigators presenting research at national meetings specifically related to the theme of the PPG. 6. Conduct and lead weekly research data meetings that will be held for investigators, fellows, technicians and students involved in the different projects and cores. 7. Support publication of new data resulting from research projects. 8. Prepare annual reports and renewals for the Program Project Grant.